Discovery and characterization of exceptionally specific surface oncoprotein LIPI in Ewing Sarcoma

Project Summary
Children and young adults with metastatic Ewing sarcoma driven by oncogenic fusion transcription factor EWS-
FLI1 continue to have poor outcomes. Immunotherapies using T cells, NK cells, cancer vaccines, and
monoclonal antibodies are being considered for Ewing sarcoma, especially for recurrent patients. The
identification of human tumor-associated antigens (TAAs) recognized by the immune system is crucial for
immunotherapy. Through integration of Ewing sarcoma cell line gene expression, ChIP-seq, and normal and
cancer tissue gene expression from the Genotype-Tissue Expression (GTEx), and the TCGA project, we have
identified LIPI as a highly specific tumor antigen and a potential oncogene that relies on the transcriptional activity
of EWS-FLI1 in Ewing sarcoma. LIPI (Lipase member I (EC:3.1.1.-) is an evolutionarily conserved protein
predicted to poses a transmembrane domain and extracellular lipid hydrolase domain. The biological function of
LIPI is not known but the enzymatic activity of LIPI is expected to produce lysophosphatidic acid (LPA) that
potently affects several biological functions including proliferation, cell survival, and metastasis of tumor cells.
We hypothesize that the LIPI is a unique biomarker and an oncogene that is expressed exclusively in Ewing
sarcoma and is a potential target for cell based therapy. To our knowledge, this proposal represents the first
study evaluating the role of LIPI in cellular physiology and in particular Ewing sarcoma progression and
metastasis. The two specific aims of the projects are:
Specific Aim 1: To elucidate the regulation and role of cell surface LIPI in Ewing sarcoma
Specific Aim 2: To investigate the role of LIPI in Ewing sarcoma growth/metastasis.
Following the successful completion of the proposed aims in this application, we will have evaluated the potential
of LIPI as a Ewing sarcoma specific surface oncoprotein, and will have a long-term impact by establishing the
strong foundation for the development of LIPI-directed immunotherapeutics against Ewing sarcoma.

Public health relevance
Project Narrative Patients with metastatic Ewing sarcoma have a less than 10% survival rate at five years; therefore, identification of novel therapeutic targets and strategies are urgently needed to treat this type of cancer. This proposal focuses on the functional characterization of LIPI as a cell surface protein with oncogenic function and a potential immunotherapy target due to its highly specific expression pattern in Ewing sarcoma. Ultimately, the results obtained from this proposal will offer significant mechanistic understanding of the players involved in Ewing sarcoma growth and metastasis as well as making a clinical impact by identifying potential targets for treating this disease through cellular therapy.